Trusted Messengers: Supporting Physicians in Promoting COVID-19 Vaccination

PROJECT SUMMARY/ABSTRACT
The severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) and associated coronavirus disease
2019 (COVID-19) pandemic have been devastating. In the United States (US), more than 25 million people
have been infected, resulting in more than 430,000 deaths. Black and Latino communities have borne a
starkly disproportionate impact of COVID-19, compounding existing health disparities. The approval of multiple
effective COVID-19 vaccines has raised hope that a return to “normal” life may be at hand, but realizing the full
benefits of vaccines will require widespread acceptance and uptake. Our work and that of others indicate a
significant proportion of the US population are reluctant to be vaccinated. Overlap between factors associated
with COVID-19 disease and COVID-19 vaccine hesitancy, including being of Black or Latino race/ethnicity, and
socioeconomic disadvantage, threaten to severely exacerbate existing health disparities. The overarching goal
of this proposal is to overcome COVID-19 vaccine hesitancy, particularly among vulnerable populations.
Building on strong existing community partnerships, we will refine, implement, and evaluate a multi-faceted
intervention to support primary care providers and community organizations as trusted messengers to promote
COVID-19 vaccination among vulnerable patients in and near Worcester, MA. Our intervention will include: (1)
an online library of videos addressing common vaccine concerns to be disseminated by PCPs and local
community organizations; (2) evidence-based text messaging from PCPs to their patients conveying
recommendations for and information about COVID-19 vaccination; and (3) concise educational materials for
PCPs to support their conversations with patients about the COVID-19 vaccine. We will implement and
evaluate the intervention via a large pragmatic clinical trial at two Federally Qualified Health Centers, and the
UMass Memorial Health Center. These three clinical systems collectively serve large populations of racial
and/or ethnic minority groups (Black, Latino, non-primary English speakers) and socioeconomically
disadvantaged patients. Our specific aims are: (1) To refine and adapt tools to support effective PCP
recommendations for COVID-19 vaccination and information dissemination by PCPs and community
organizations to vulnerable patients; (2) To implement and assess the impact of the intervention on COVID-19
vaccine uptake among initially unvaccinated patients and (3) To evaluate the intervention according to the RE-
AIM framework, incorporating the perspectives of patients, primary care providers, and clinic leaders. We will
characterize the local community environment before, during and beyond the intervention period and will
identify ways the environment supports or inhibits intervention effectiveness. This research will generate
crucial evidence of how to effectively promote COVID-19 vaccination among vulnerable populations. Our
findings can be applied to promote uptake of other vaccines (including possible COVID-19 vaccine “boosters”)
among populations at risk of vaccine hesitancy and health disparities.

Public health relevance
PROJECT NARRATIVE This project will develop and test tools and resources to support primary care providers and community organizations in promoting COVID-19 vaccination among vulnerable populations at risk for COVID-19 related health disparities and reluctance to be vaccinated. Our findings can be applied to promote uptake of other vaccines (including possible COVID-19 vaccine “boosters”) among populations at risk of vaccine hesitancy and health disparities.